Task A24: Establishment of Chronic Pseudomonas aeruginosa and Staphylococcus aureus Infection in Mouse Models of Cystic Fibrosis

This contract provides for the development and standardization of small animal models of infectious diseases for biodefense and other emerging pathogens, and may include efficacy testing of candidate products, including GLP studies to support licensure.